Robust immune tolerance conferred by Foxp3 transcriptional regulation

Robust immune tolerance conferred by Foxp3 transcriptional regulation
Regulatory T (Treg) cells actively suppress self-destructive T cells that cause a variety of autoimmune
diseases. Despite significant progress, Treg-based treatment is significantly constrained by limited methods to
improve Treg suppressive capacity. We aim to dissect the mechanistic processes of Treg induction and lineage
maintenance to uncover the factors and mechanisms conferring robust immune suppressive function. Treg cells
are induced by the convergence of environmental cues delivered to differentiating T cells with considerable
variations, resulting in stochastic Treg development. Besides, the DNA sequences of the genetic elements
regulating Treg lineage identity also vary among individuals. Given the enormously diverse T cell antigen
receptors (TCRs) and target specificities, Treg cells are induced with many uncertainties. Once committed, Treg
fate is maintained for extended suppressive function by cell-intrinsic and -extrinsic factors that constantly
fluctuate. All these uncertainties raise a question about how robust immune tolerance is conferred by Treg cells.
Study of Treg master regulator Foxp3 offers a unique approach to address this question, because Foxp3
expression centers Treg fate determination and function. We hypothesize that an adequate buffering capacity
conferred by efficient Treg development and lineage stability opposes the genetic variations and immune
perturbations. To test this hypothesis, we examined the Foxp3 enhancers that dictate Treg induction and lineage
stability. Individual Foxp3 enhancers were known to play stage-specific roles in Foxp3 induction or maintenance.
However, mice bearing their individual mutations develop mild if any immune dysregulation despite significant
defects in Treg development or lineage stability. To solve this mystery, we examined the epigenetic mechanisms
mediating Foxp3 expression and hypothesize that Foxp3 enhancers coordinate to enable efficient Treg induction
or stable lineage identity for adequate Treg buffering capacity.
We generated new mouse strains to test our hypotheses and found that deletion of two interacting Foxp3
enhancers caused fatal autoimmune diseases accompanied with severe defects of Treg induction or lineage
stability. This result together with other studies delineates a full spectrum of Treg buffering capacity acquired
through coordinating Foxp3 enhancers. In the proposed study, we will fully uncover the immunological
consequences of mice with severely reduced Treg induction or lineage stability. We will develop new algorithms
and use single cell RNA sequencing to assess Treg repertoire diversity and lineage stability to infer Treg buffering
capacity. We will also use our newly developed mouse genetic tools to determine the role of continuous thymic
Treg induction in maintaining the Treg buffering capacity.
Overall, our study will uncover a full spectrum of Treg suppressive capacity conferred by Foxp3
transcriptional regulation. It will improve our basic understanding of Treg-related autoimmune diseases.

Public health relevance
Robust immune tolerance conferred by Foxp3 transcriptional regulation Regulatory T cells actively suppress self-destructive T cells that cause a variety of autoimmune diseases. We propose to uncover the mechanisms governing the suppressive capacity of regulatory T cells conferred by their induction and lineage stability through their master regulator Foxp3.